DERMATITIS HERPETIFORMIS AND THE MUCOSAL IMMUNE RESPONSE

The purpose of this study is to characterize the mucosal immune response to dietary antigens in patients with dermatitis herpetiformis and normal subjects by collecting blood, saliva, and intestinal secretions.